Biogenesis of macromolecular machines for post-transcriptional regulation of translation

SUMMARY
Non-coding RNAs (ncRNAs) are integral components of many essential RNA-protein complexes
(RNPs) required for key cellular functions. As such, RNPs play a pivotal role in regulating gene
expression and their dysregulation can result in pathological conditions including neurodevelopmental
disorders, cancer, and neurodegeneration. The regulation of RNP formation governs the activity of
crucial cellular machinery such as the telomerase, spliceosome, small nucleolar RNPs (snoRNPs), and
the ribosome, yet much of this regulation remains poorly understood. My lab’s research focuses on
revealing the molecular mechanisms that regulate RNP assemblies with an emphasis on snoRNPs and
ribosomes. snoRNAs, an abundant class of small ncRNAs, play essential roles in guiding the
processing and modifications of ribosomal RNAs (rRNAs), and their dysregulation is pathogenic. The
deposition of numerous modifications on rRNA by snoRNPs is critical to control the quantity and quality
protein synthesis. However, the significance of individual rRNA modification sites remains largely
unknown to date. My research plan aims to understand the molecular connections between snoRNA
regulation, rRNA modification pattern and translation regulation, using a multi-pronged technical
platform that employs yeast genetics, biochemistry, advanced high throughput sequencing approaches,
and mass spectrometry. This proposal builds on novel genetic tools and preliminary data to answer
three fundamental questions: 1) How are snoRNA maturation and assembly coordinated with
transcription? 2) How do rRNA modifications regulate translation? 3) How are snoRNAs and snoRNA-
mediated rRNA modifications regulated? Understanding the intricate regulation of snoRNP biogenesis
is crucial for revealing gene expression mechanisms that control translation and may offer potential
therapeutic interventions in diseases linked to snoRNA dysregulation. Dissecting the contribution of
rRNA modifications to translation will offer insights into faithful ribosome function and potential avenues
for preventing translation dysregulation. Elucidating snoRNA regulation mechanisms across different
biological contexts will reveal the common signatures and regulatory trends in this pathway that go
awry in disease. Together, our studies will provide significant insights into the control of gene
expression by snoRNAs with a potential to inform our view of how such dysregulations contribute to
human disease.

Public health relevance
Public Health Relevance Statement: This project aims to define the mechanisms governing the abundance and regulation of function of a crucial class of non-coding RNAs, that play key roles in optimizing ribosome production for efficient and precise synthesis of cellular proteins. Dysregulation of these RNAs, and consequently protein synthesis, results in gene expression abnormalities leading to human diseases. Revealing the molecular mechanisms of these fundamental gene expression processes holds significant implications for public health, offering potential novel targets for therapeutic intervention.